Dissecting the pathogenesis of HIV-TB Immune reconstitution inflammatory syndrome

Despite major advances in global health care, there were an estimated 1.5 millions deaths and 10 million new
cases of tuberculosis (TB) in 2018. Nearly 1 million people living with HIV developed tuberculosis (TB). Co-
infection with HIV and TB is associated with high morbidity and mortality and treatment with TB drugs and anti-
retroviral (ART) therapy is now universally available. TB drug treatment followed by ART improves long term
survival, particularly among those whose immune systems are severely suppressed from HIV infection. Signs
and symptoms of disease improve soon after treatment is started but, in many cases, disease can recur and
appear clinically worse as the immune system is being re-established from ART. This is known as TB-
associated Immune Reconstitution Inflammatory Syndrome (TB-IRIS) and is more common among patients
with severely suppressed immune systems before treatment and those who have a short time interval between
starting TB treatment and ART. Very little is known about how or why TB-IRIS occurs and how to best to treat
or even prevent it. We hypothesize that symptoms of TB-IRIS are driven by the dynamic interaction between
the immune system, Mycobacterium tuberculosis (Mtb, the bacteria that causes TB) and HIV deep within
infected tissues in the body such as the lung granuloma. Virtually nothing is known about what happens in the
tissues where both Mtb and HIV interact during TB-IRIS. This proposal will develop an animal model of TB-
IRIS by taking advantage of our pre-existing model of HIV-TB co-infection in which animals with SIV-Mtb co-
infection undergo TB drug treatment and ART just like humans. We will use sophisticated imaging,
immunology and microbiologic tools to better understand how and why TB-IRIS develops and what factors can
predict its emergence. Aim 1 will determine how often TB-IRIS occurs in this model and to what extent Mtb and
SIV remain in the tissues during treatment. We will also perform a detailed examination of the changes that
occur in the tissues but especially the lungs (granulomas) and lymph nodes through serial in vivo images to
better understand the events that lead to TB-IRIS and its predictors. In Aim 2, we will perform a detailed
examination of the immunologic events in the tissues and blood during TB-IRIS. Tissue specific (lung
granulomas and lymph nodes) immune responses will be correlated with the amount of Mtb bacteria and virus
with the imaging findings so that we can better understand the causes of TB-IRIS. Our short term goal is to
better understand the pathogenesis of TB-IRIS in this proposal and these findings will ultimately lead to better
treatment and prevention of TB-IRIS which is our long term goal.

Public health relevance
Patients infected with both HIV and tuberculosis (TB) are at extremely high risk of death and long-term morbidity if they survive. Early treatment of both infections vastly improves long-term survival but there is a risk of TB-associated immune reconstitution syndrome (TB-IRIS) in which the symptoms of disease improve but then recur sometimes more severely than before treatment. Give that very little is currently understood about this process of TB-IRIS, this proposal identifies the basic mechanism of this poorly understood disease process and develop better strategies for prevention and treatment.